Astrocyte-neuron mechanisms of glutamatergic modulation in social novelty recognition

Project Summary
Social behavior is a fundamental component of complex behaviors for animals to sustain healthy living patterns.
Consequently, deficits or dysfunctional social behaviors are found in multiple psychiatric and neurological
disorders, such as autism spectrum disorder (ASD). Recently, a growing body of research demonstrates a
significant adaptation of astrocytes, non-neuronal glial cells in the brain, in the etiology of ASD. However, the
detailed mechanisms underlying how astrocyte dysfunction represents social behavioral deficiency remain
poorly understood. Particularly, the challenge is exaggerated by the lack of knowledge about whether and how
the local astrocytes affect the ASD-phenotype brain in cell-type, circuit, and network levels.
Abnormal glutamatergic transmission contributes to aberrant hyperexcitability in brain regions critical for
controlling social behaviors by shifting the excitation-to-inhibition ratio. Excess glutamate is typically cleared from
the synaptic cleft into astrocytes via glutamate transporters. Our recent studies revealed that astrocyte activation
in the paraventricular nucleus of the thalamus (PVT), a hub of communications in thalamo-cortical circuits where
processes the sensitivity to external social environmental stimuli, impairs social novelty recognition while
parallelly downregulating functional astrocyte dominant glutamate transporter type 1 (GLT1; EAAT2 in humans).
Interestingly, astrocyte-specific conditional knock-out of GLT1 in the PVT mimics the impairment of social novelty
recognition, reinforcing the importance of the glutamatergic system in astrocyte-based social behavioral
modulation. Thus, based on our findings, we hypothesize that astrocytic modulation of glutamatergic signaling
has an important role in the regulation of social novelty recognition. Chemogenetic activation of astrocytes,
mimicking reactive calcium-increased astrocytes and sequentially reducing GLT1 function, impairs the normal
response of astrocytes in the PVT to neuronal activity and this, in turn, contributes to abnormal social recognition.
In contrast, GLT1 overexpression facilitates the maintenance of normal social recognition behaviors. To
investigate this hypothesis, first we will investigate the spatiotemporal glutamate and calcium signals
synchronized to social behaviors in the astrocytes and neurons and their adaptation by GLT1 modulation.
Second, we will examine the contribution of PVT GLT1 null and overexpression in synaptic events and
metabolism in the PVT circuits, and consequent social novelty recognition behaviors. Finally, we will determine
whether astrocytic glutamate modulation via GLT1 affects the brain-wide spatiotemporal signature, and the brain
network coherence provides any distinguishable profiles that represent social behavioral outcomes.
Our study will elucidate the detailed mechanisms of astrocyte-neuron interaction via the glutamate
system encoding social novelty recognition. We will provide a rational path for the development of new
therapeutic methods for the treatment of social behavioral deficits.

Public health relevance
Project Narrative Although astrocytes are key components of brain circuits underlying voluntary behaviors and proposed an important layer of regulating social behaviors, yet the underlying mechanisms are poorly understood. We will investigate astrocyte and neuron interactions in regulating social novelty recognition that involve glutamatergic signaling using multi-layered cutting edge experimental evaluation with computational approaches. At its conclusion, this work will illuminate novel targets that can reduce the devastating social behavior-related psychiatric and medical consequences such as autism spectrum disorder.